GH23-001 - Strategic Operational Research to Accelerate Control and Elimination of Neglected Tropical Diseases (NTDs) in sub-Saharan Africa - RACE

PROJECT SUMMARY
The proposed project will be implemented in priority sub - African countries. Prioritization of implementation
sites is based on the CDC’s list of target countries.
The project seeks to carry out strategic operation research that will provide evidence for NTD national
control programs to fast track their progress towards controlling and eliminating of NTDs within their
borders, by evaluating diagnostic tests for NTDs, testing approaches that may potentially supplement mass
drug administration (MDA) as a strategy for control of vectors that cause NTDs and providing evidence for
lower thresholds for stopping mass strategies such as MDAs. If lower thresholds are confirmed, savings
would be made, and such resources could be diverted to other public health programs. This is especially
important in Africa where resources can barely meet the demands on already constrained health systems.
Proposed activities will be implemented in close liaison with national NTD program staff, as a means of
building their capacity, to ensure knowledge and skill transfer, and sustenance of initiatives.
The anticipated overall outcome of this project is reduced morbidity and mortality from NTDs, primarily in
Africa, but in the world at large.

Public health relevance
PROJECT NARRATIVE This project will advance implementation research projects and evaluation activities to inform the elimination and control of Neglected Tropical Diseases (NTDs) through the provision of knowledge, skills, tools and information for national NTD programs to use in planning and implementing NTD control intiatives in sub-Saharan Africa.